NOVEL PREPARATIONS FOR STUDIES OF CARDIAC &FLIGHT MUSCLE FROM DROSOPHILA

It is proposed to systematically investigate the suitability for X-ray analysis of the individual preparations for 10 rat trabeculae or papillary muscle, or ventricular wall and 2) Drosophila flight muscle single fibers. The goal is to find out how much detail in how little time with a known number of incident photons.